Addressing Disaster Displacement for Recovery with Equitable and Sustainable Systems (ADDRESS) of HIV Care in Puerto Rico

Project Abstract/Summary:
Career Goal. My long-term career goals are: (1) to obtain and secure a full-time tenure track faculty
appointment and (2) become an independently funded health equity researcher who partners with public and
private stakeholders to assess the health impact of natural events, and produce evidence-based, culturally
informed interventions, and systems change to reduce the overall and inequitable burden of HIV mortality and
environmental determinants of HIV care, especially among Black, Latine, and immigrant communities.
Career Development. This K01 research and training plan will catalyze my efforts to acquire the advanced
training necessary to develop and plan an intervention addressing the intersection of natural event-based
displacement and HIV treatment adherence and continuity. My training goals consist of (1) pursuing advanced
training in longitudinal statistical quantitative methods necessary to examine the long-term impacts of natural
events on the health of people with HIV (PWH); (2) acquiring expertise in the application of Social Network
Analysis (SNA) methods to identify the networks that facilitate and limit HIV treatment continuity and ways to
leverage networks to improve natural event related HIV care continuity; and (3) developing advanced
competencies in implementation science to design an intervention prototype for an R01 network intervention.
Research Project. This proposed five-year mixed-methods project explores the health implications of natural
event-driven displacement for PWH in San Juan, PR. It aims to establish the link between natural event-related
displacement and PWH's continuity of care and mental health. The study addresses how HIV providers, PWH,
and organizations respond to natural events to bridge service gaps amid temporary or permanent
displacement. Employing SNA and longitudinal analysis it investigates how strategies at individual, community,
and government levels can be created with social network to improve HIV treatment continuity and mental
health support during natural events.
Specific Aims. Aim 1. Determine the displacement generated by natural events and the impact on HIV and
mental health care in PR. Aim 2. Identify the role of social networks related to natural event response for HIV
and mental health care continuity in PR. Aim 3. Systematically develop an intervention prototype,
implementation, and dissemination plan for HIV care continuity around natural events using the 6 quality steps
for intervention development (6SQuID) model in conjunction with the Health Promotion Research Center for
(HPRC) Dissemination Framework. Mentorship Team: My efforts will be guided by an accomplished,
interdisciplinary team of mentors committed to support my transition to an independent investigator.

Public health relevance
Project Narrative: This study investigates the disruptions and displacement effects of natural events and their influence on HIV treatment continuity and mental health in Puerto Rico (PR) using electronic health records. It also explores the role of social networks in HIV care and mental health continuity during natural events, aiming to develop an intervention prototype with implementation and dissemination recommendations based on findings. Dr. Casanova will acquire training in longitudinal analysis, social network analysis, and intervention design for achieving these research aims.